Stigmatizing Language in Cancer Care Electronic Health Records

PROJECT SUMMARY/ABSTRACT
Healthcare and research organizations, including the American Society for Clinical Oncology, acknowledge the
common use of stigmatizing language in cancer care. However, stigmatizing language has not been
comprehensively defined, and drivers and outcomes of this language use have not been investigated in cancer
care. One way that discrimination and stigma manifest in the healthcare system is through the electronic health
record (EHR), which can reflect the author’s implicit and explicit bias. Reading stigmatizing language alters
readers’ clinical decisions in vignette studies. Thus, there is an opportunity to evaluate EHR stigmatizing
language as a modifiable mechanism of decreasing discrimination and improving outcomes in cancer care.
The long-term goal is to evaluate sociocultural and healthcare system influences of EHR stigmatizing language
and resulting changes in clinical decision-making in cancer care. The central hypothesis is that stigmatizing
language is present in the cancer care EHR, inequitably experienced, and associated with altered clinical
decision-making. The hypothesis will be tested via the following specific aims: (1) Determine the categories of
stigmatizing language used by oncology clinicians when documenting patient encounters in the EHR; (2)
Compare stigmatizing language in the cancer care EHR by patient and clinician characteristics; (3) Determine
if stigmatizing language use is associated with disparities in medication prescription for cancer-related pain.
This study will leverage EHR data from a large academic and community healthcare system in Minnesota. Aim
1 utilizes a qualitative study design to perform a directed content analysis of the unstructured, free text section
of outpatient oncology EHR notes. Aims 2 & 3 use natural language processing to abstract stigmatizing terms
and phrases for each individual with outpatient cancer visits in 2022. Multilevel models will be utilized to
account for nested visit-level data within patient-level data within clinician-level data. This project is innovative
in its characterization and modeling of stigmatizing language in cancer care and will have significant impact by
informing interventions to reduce stigma, health disparities, and resulting negative health outcomes. By
focusing on EHR stigmatizing language, this project addresses emerging opportunities and challenges as
medical records become accessible to patients and persist throughout their lives. The applicant is an MD/PhD
and Epidemiology PhD student at the University of Minnesota Schools of Medicine and Public Health. By
expanding content knowledge in cancer survivorship and disparities, rigorous qualitative and quantitative
analysis skills, tailored clinical training, and focused professional development opportunities, this fellowship will
enhance her ability to excel in the MD/PhD program and become an independent academic physician-
epidemiologist.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health because healthcare discrimination is common, inequitably experienced, and associated with worse health outcomes. One way discrimination and stigma manifest in the healthcare system is through electronic health record (EHR) documentation; the prevalence and impact of EHR stigmatizing language in cancer care has not been investigated but may contribute to disparities in clinical decision-making and patient outcomes. Thus, this research aligns with the NIH’s mission to lead research in cancer survivorship, reduce health disparities, and help all people live longer, healthier lives.